The CHESS (Community, Home-based Education, Screening Services) Strategy to increase cervical cancer control access for HIV positive women in Nigeria

Abstract
Despite the increased risk of cervical cancer (CC) for women living with HIV (WLWH), access to CC screening
in Nigeria is limited. Access to screening, prevention programs, and highly active antiretroviral therapy has
contributed to dramatic declines in the incidence of many AIDS-associated malignancies but have not lowered
CC risk in WLWH. Therefore, we seek to leverage the existing HIV treatment infrastructure in Nigeria to
integrate home-based CC (HCC) screening for WLWH and evaluate the implementation and sustainability of
this model. We will weave HCC activities into the successful, long-standing MoMent (MOther MENTor) peer-
based HIV support program and evaluate the implementation of this adapted program for adoption, integration,
sustainability, and potential for national scale-up. The Consolidated Framework for Implementation Research
(CFIR) and Reach, Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) conceptual
frameworks will guide our implementation and impact evaluation. In this project, we will pursue three specific
aims: 1) use a stakeholder deliberation conference methodology to adapt the successful MoMent program to
promote home-based HPV CC screening and follow-up treatment for women who are HIV positive; 2)
implement the MoMent HIV+HCC screening program and assess program reach, effectiveness, adoption, and
fidelity; and 3) conduct post-implementation process evaluation of barriers and enablers to program
maintenance and sustainability. Stakeholder input from WLWH, peer counselors, clinical managers, and
federal/state policymakers will shape the adapted program and promote its successful implementation in a
sample of 1,500 WLWH. We will be among the first to apply recent systematic review findings that the
“characteristics of systems” construct of CFIR is particularly relevant in low/middle income countries. We
ensure scalability by focusing on national and state policymaker perspectives in the pre-implementation,
implementation, and maintenance phases of the adapted program. In this project, we will advance CC control
for WLWH in Nigeria and generate data that can inform effective adaptation and implementation of evidence-
based cancer control strategies for people living with HIV in low/middle income countries worldwide.

Public health relevance
Project Narrative Despite the increased risk of cervical cancer for women living with HIV, access to cervical cancer screening in Nigeria is limited. We will leverage existing HIV treatment infrastructure in Nigeria to integrate cervical cancer control activities into the successful MoMent (MOther MENTor) peer-based HIV support program. Using implementation science frameworks, we will implement and evaluate the sustainability of the adapted MoMent HIV + Homebased Cervical Cancer program to advance cervical cancer control in Nigerian women living with HIV.